Immune Mediators of IL-22 Signaling Alter Allergic Airway Disease

PROJECT SUMMARY
Allergic asthma affects approximately 300 million people worldwide. As the incidence of asthma continues to
rise, studies linking immune and pathophysiologic mechanisms to asthma endotypes are of great importance
to establish more targeted and effective therapies. Severe, steroid-insensitive (non-eosinophilic) asthma
accounts for greater than half the current disease burden, but few studies have focused on modeling this
disease subset. In severe refractory disease, allergen-specific, steroid-insensitive T helper (Th) 17 and/or Th2
cells are thought to critically orchestrate asthma pathogenesis, resulting in pulmonary inflammation, mucus
hypersecretion, and airway hyperresponsiveness. The Th17 immune cytokine interleukin (IL)-22 plays a vital
role in maintaining epithelial integrity and promoting repair. IL-22 receptor alpha-2 (IL-22Ra2), a soluble
receptor for IL-22, inhibits its activity. The significance of IL-22 and endogenous IL-22Ra2, as well as the
pathways that regulate them in severe asthma, are unknown. Aside from IL-22Ra2, type I interferons (IFN),
consisting of IFNα subtypes and IFNβ, are immunomodulators that alter IL-10 and IL-22 signaling in certain
inflammatory disease contexts. Based on our preliminary and published findings, we hypothesize that IL-
22Ra2 and type I IFNs perpetuate severe allergic airway disease (AAD) by blocking IL-22 signaling,
which is necessary to alleviate AAD and maintain epithelial integrity in the lung. The following aims will
investigate this hypothesis: 1) Investigate whether IL-22Ra2 modulates severe AAD by altering IL-22
bioavailability in the lung, 2) Determine if type I IFNs promote severe AAD by inducing IL-22Ra2 and limiting
IL-22 activity in the lung, and 3) Examine if IL-22 signaling in the epithelium of the lung alleviates severe AAD
and maintains epithelial integrity in the lung. The proposed work in this application will pioneer investigations
into the role of IL-22Ra2 and type I interferons as regulators of allergic disease and will uncover the potential
molecular mechanisms by which the IL-22 axis protects the lung epithelium during AAD. This novel work in a
preclinical animal model and human samples will uncover new therapeutic targets for the treatment of severe
asthma that is poorly responsive to standard therapies.

Public health relevance
PROJECT NARRATIVE Severe, drug-resistant asthma is a growing public health issue in the United States and worldwide, creating a large burden on the health care system. The goal of this proposed work is to understand aberrant immune responses in severe asthma, a subset of disease that is poorly responsive to standard therapies. Our novel focus on the role of immune mediators, interleukin-22 binding protein, type I interferons, and interleukin- 22, in severe asthma will identify targets for the development of new therapeutic approaches.